Quantitative Determination of High-Order Protein Structure with Native Ion Mobility-Mass Spectrometry and Computational Chemistry

PROJECT SUMMARY/ABSTRACT
Characterizing the structures and interactions of biomolecules and their complexes is of fundamental
importance in human physiology, disease, and therapeutics. Many of the advances of the last century in these
areas are attributed to improvements in bioanalytical techniques and controlling the processes that underlie
them. For example, x-ray crystallography, nuclear magnetic resonance spectroscopy, and cryoelectron
microscopy have achieved atomic-level resolution of the structure of many thousands of proteins and protein
complexes, and these methods are often complemented by Molecular Dynamics studies to further understand
biomolecule structure and reactivity. However, these methods can be challenging to use for very small or highly
heterogeneous samples or samples that require a membrane environment. Native Ion Mobility-Mass
Spectrometry (IM-MS) is a complementary technique that ionizes and transfers intact biomolecules and
complexes directly from buffered, aqueous solution into the gas-phase for mass and shape/size analysis, and
modern sample preparation and data analysis methods make it highly suitable for membrane proteins in lipid
environments as well as heterogeneous and polydisperse samples. In commonly available IM-MS
instrumentation, Collision Induced Dissociation and Unfolding are used to activate native biomolecular ions by
colliding them repeatedly with neutral buffer gas until they dissociate or unfold, and recently-introduced Surface
Induced Dissociation and Unfolding activate ions via a single, controlled collision with a hard surface inside the
mass spectrometer. These native IM-MS methods can be extremely useful for profiling the composition, size,
and shape of biomolecules and their complexes with exquisite chemical specificity, sensitivity, and speed.
However, two major hurdles to the use of these methods for accurate, quantitative interpretation of biomolecule
domain, surface, and interface structure are the lack of a flexible, robust method for computing and interpreting
the energy required to induce the observed structural changes and a dearth of reliable benchmark values. Here,
we tackle these challenges with a combined computational and experimental approach aimed at producing a
“universal,” validated ion activation model that can be readily used for across many commonly used native MS
and IM-MS platforms and by producing a benchmark library for prototypical local and large-scale interactions
that govern protein unfolding, dissociation, and surface labeling. Expected outcomes include open-source,
publicly available software for researchers world-wide to model unfolding/dissociation energetics for their own
samples, heuristics for the design of effective gas-phase surface-labeling reagents, and a quantitative
understanding of cataract-associated human eye lens protein heterooligomerization as a case study. The long-
term goal of the project is to facilitate the acquisition and interpretation of decisive structural and dynamical
information for a wide range of biomolecules and complexes relevant to human health.

Public health relevance
PROJECT NARRATIVE Native Ion Mobility-Mass Spectrometry (IM-MS) can reveal a wealth of information about the structure of biomolecules and their complexes, especially when combined with activation methods used to disrupt physiological structures and expose their more detailed architecture. Short-term goals of the proposed research include developing theory and experimental methods to boost the power of these methods by relating activation energies and entropies to structural information. The long-term goal of the proposed research is to provide academic, pharmaceutical, and clinical researchers with robust experimental and computational tools needed to quantitatively analyze structure and behavior of biomolecules relevant to human health while harnessing the specificity, sensitivity, speed, and tolerance to heterogeneity of native IM-MS.